Small Molecule Glycoside Inhibitors of LecB for the Treatment of Pseudomonas Infections

Project Summary/Abstract
Pseudomonas aeruginosa (Pa) is a Gram-negative bacterium and opportunistic pathogen capable of persisting
in diverse environments and causing numerous human infections including: skin, soft tissue, joint, blood
stream, and lung infections. Pa infections most frequently occur in patients with compromised immune or
barrier functions, especially in patients with compromised lung function such as those with cystic fibrosis (CF)
or chronic obstructive pulmonary disease. Once established, Pa infections are increasingly difficult to treat as
the high mutation rate and the promiscuous acquisition of mobile genetic elements containing antimicrobial
resistance systems by Pa has augmented its already high intrinsic antibiotic resistance, resulting in the
emergence of antimicrobial resistant (AMR) Pa isolates. Pa infections, especially those caused by AMR Pa,
result in high levels of morbidity and mortality and dramatically increase healthcare costs to afflicted patients.
Therefore, new and safe drugs, with novel mechanisms of action are desperately needed to effectively treat Pa
infections and reduce the emergence AMR Pa. Further exacerbating this high AMR is the ability of Pa to form
biofilms in environmental and host niches. Biofilms are complex communities of bacteria incased in a polymeric
matrix that reduce the efficacy of antimicrobials by numerous mechanisms. The use of biofilm inhibitory
compounds has been shown to enhance the efficacy of antibiotics in in vitro systems and in in vivo Pa infection
models suggesting that this strategy could help alleviate the AMR Pa burden. The Pa lectin, LecB, is a fucose
and mannose binding protein that is essential for biofilm formation and contributes to pathogenesis. The
inhibition of LecB function using exogenously administered fucose- and/or mannose-based binding antagonists
reduces in vitro biofilm formation and enhances the efficacy of antibiotics in in vivo models of Pa lung infection.
Fimbrion is collaborating with Dr. Alexander Titz to develop a small molecule series of high affinity fucose-
based glycomimetics that target the LecB sugar binding site. The current series of LecB antagonists display
increased potency (up to 200-fold more potent than fucose), excellent in vitro solubility and stability with good
in vivo oral bioavailability (34%). Critically, an early lead LecB inhibitor is able to enhance the efficacy of
tobramycin in a mouse model of Pa lung infection, providing proof-of-principle for this approach. In Aim 1 of our
SBIR Phase I, we will focus on generating a library of LecB inhibitors with optimized potency and
pharmacokinetic (PK) properties, while maintaining tge solubility, safety, and stability properties of the early
compounds. In Aim 2 we will test a set of compounds with the best combination of the above characteristics for
in vivo safety in a maximum tolerated dose study, for dose/exposure linearity in a dose escalation PK study,
and for efficacy in a mouse model of Pa lung infection. Success in this Phase I project will be defined as
identifying potent and orally bioavailable LecB inhibitors with sufficiently large therapeutic widows to allow the
dosing necessary to achieve antibiotic enhancing activity in mouse models of Pa lung infection.

Public health relevance
Project Narrative: Pseudomonas aeruginosa (Pa) is an environmental bacterium and opportunistic pathogen capable of causing numerous infections including chronic lung infections, especially in patients with predisposing factors such as cystic fibrosis or chronic obstructive pulmonary disease. Treatment of these infections is increasingly difficult as Pa has a high level of intrinsic antimicrobial resistance, promiscuously acquires additional resistance mechanisms, and forms treatment recalcitrant biofilms. In this application, we propose to optimize a series of inhibitors of the Pa virulence factor and biofilm mediator LecB that will act as antibiotic enabling agents to counteract the emerging antimicrobial resistance of Pa and improve treatment outcomes.